Polarized Exocytosis: Rabs, Tethers, and SNAREs

Abstract
The overall goal of this proposal is to understand the mechanism by which Rho GTPases,
Rab GTPases, tethering agents, and SNAREs contribute to direct polarized trafficking and growth
at the cell surface. Previous work from our laboratories and others has implicated members of the
Rho/Cdc42, exocyst and Sro7/Tomosyn protein families as highly conserved factors that have
important roles in both polarity and membrane trafficking to the cell surface in systems as diverse
as yeast and neurons. In this proposal, we will make use of new biochemical, genetic, and
structural tools we have developed during the previous funding period to examine the molecular
mechanisms by with Exocyst and Sro7 proteins work together as Rab effectors and vesicle
tethering agents. Importantly we make use of newly identified gain-of-function alleles within the
exocyst and Sro7 to understand the distinct biochemical and structural changes that occur to these
tethering agents as they respond to regulatory and spatial cues.

Public health relevance
Project Narrative: Our investigation into the fundamental mechanisms by which cells direct growth is likely to be relevant to our understanding of a diverse set of human diseases including tumor development and Type II diabetes as defects in this process has been associated with a number of cancers and insulin responsiveness in humans. A molecular understanding of how these highly conserved processes carried by a highly conserved machinery will allow development of new approaches and novel therapeutics to combat disease.